SEMA7a regulation of tooth mineralization, root elongation, and innervation

PROJECT SUMMARY/ABSTRACT
The development of healthy molar teeth with elongated roots, mineralized dentin, and sensory innervation re-
quires coordinated efforts between neuronal and mesenchymal tissue. During the first week of development,
mouse molars begin all three developmental processes of secreting a dentin matrix, initiating root elongation,
and secreting chemoattractants to guide sensory afferent penetration into the pulp tissue. Research has shown
that disrupting pulp mesenchyme signals during this period can have drastic effects on one or more of these
processes. These coordinated processes are conserved in humans and pose clinical challenges for pediatric
dentists and endodontists attempting to ensure the long-term vitality of an infected or damaged immature tooth.
The long-term goal of this project is to understand the cellular mechanisms that protect teeth via dental tissue
crosstalk. The objective is to determine the mechanisms that regulate the development of a tooth into a miner-
alized, anchored, sensory organ. Our central hypothesis is that Sema7a signaling from differentiating odonto-
blasts regulates tooth mineralization, root elongation, and innervation. This hypothesis was formulated because
our mouse model of conditional Tgfbr2 deletion in tooth mesenchyme demonstrated reduced mineralization,
root elongation, and innervation coinciding with reduced Sema7a RNA expression in the DP and aberrant lo-
calization of SEMA7a in the apical regions of the developing teeth. Guided by our previously generated data,
we will test our hypothesis with the following two specific aims: 1) To determine the impact of global and condi-
tional deletion in dental pulp mesenchyme of Sema7a on dentin mineralization, root elongation, and tooth in-
nervation; and 2) Isolate the role(s) of SEMA7a signaling to DP neuronal and mesenchymal populations with in
vitro assays. Under the first aim, we will analyze tooth morphology, including the dentin volume, density, and
thickness, root length, and tooth innervation using the Sema7a-/- mouse model in addition to a conditional
knockout mouse with Sema7a deletion induced by the osterix-promoter driven Cre recombinase induced at
postnatal day 3. For the second aim, we will utilize a co-culture model with primary dental pulp cells and tri-
geminal neurons to assess whether SEMA7a regulates the processes of odontoblast differentiation, matrix
deposition and neurite outgrowth. The research proposed in this application is innovative because it a) investi-
gates a previously unrecognized chemoattractant involved in the process of tooth development during the criti-
cal window of time during the initiation of matrix deposition, root elongation, and tooth innervation; and b) pro-
poses to be the first study to examine tooth development in models with global and conditional deletion of
Sema7a. The proposed research is significant because it is expected to advance the understanding of how
these three developmental processes are regulated during a critical window of time during postnatal tooth de-
velopment. Ultimately, such knowledge has the potential to bolster regenerative endodontics to treat injuries
and disease states, and to ensure the proper development and long-term retention of healthy teeth.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it aims to understand the cues guiding tooth develop- ment, which can be used to develop better preventative and treatment strategies for our dentition. This re- search stands to reveal candidates to test in follow-up tooth regeneration experiments that could help develop new pulp therapies and greatly improve dental healthcare at all stages of life. Thus, the proposed research is relevant to the NIDCR’s mission to improve dental healthcare through research and dissemination of health information.